Project 2 - Shh and Etv2 Signaling Pathways and Cardiovascular Repair in Mouse and Pig

ABSTRACT
Cardiovascular disease is common and deadly. While lower organisms have a tremendous capacity for
regeneration, the adult mammalian heart is more limited in its capacity for regeneration and remuscularization
of the damaged tissue following an injury such as a myocardial infarction. Recently, we defined an evolutionary
conserved Shh signaling pathway in newt and mouse that promotes cardiomyocyte proliferation in vitro and
cardiac repair. Our preliminary data support the hypothesis that Gli1 (a downstream effector of Shh) is a direct
upstream regulator of Sox4 gene expression and Gli1 overexpression promotes cardiomyocyte proliferation in
vitro. Furthermore, we have demonstrated that Etv2 is a master regulator of the endothelial lineage and is
necessary and sufficient for angiogenesis in mouse and pig. Importantly, the results of these studies provide a
platform for the proposed studies that will dissect the mechanisms that govern cardiovascular repair and
proliferation. Therefore, our overall hypothesis is that the Shh downstream effectors, Gli1/Gli2, regulate
cardiomyocyte proliferation in a Sox4 dependent manner and Etv2 promotes endothelial/vascular
development to collectively promote cardiac regeneration. In these proposed studies, we will use a
number of novel genetic models and large animal models that are available in our laboratory (and the cores),
bioinformatics algorithms that we developed and we take an innovative approach to dissect the role of Gli1,
Etv2 and Sox4 as important factors that govern cardiovascular repair and proliferation. To examine our
hypotheses, the revised Project 2 proposal will address the following specific aims: Specific Aim #1: To
define the capacity of Gli and Etv2 deficient hearts for growth and regeneration; Specific Aim #2: To
determine the impact of Gli1 and Etv2 overexpression on cardiac repair and regeneration and Specific
Aim #3: To define the mechanistic role of Sox4 in the cardiomyocyte lineage. These aims will
complement and synergize with the other projects. They will utilize our recently engineered genetic mouse
models, inducible viral vectors, modified mRNA-GFP constructs, mouse and pig models, molecular analyses
and bioinformatics algorithms to comprehensively define the role for Gli1, Etv2 and Sox4 as essential factors
that govern cardiac repair and regeneration by promoting cardiomyocyte proliferation and angiogenesis
following injury. Given the tremendous morbidity and mortality of cardiovascular disease in our society, the
potential impact of this proposal is tremendous.

Public health relevance
NARRATIVE Cardiovascular disease is common and deadly. The long term goal and the clinical significance of this revised Project 2 proposal are to define the factors that promote heart cells to divide, repair and regenerate the injured heart. The results from these studies will serve as an important platform to enhance future therapeutic initiatives aimed at heart regeneration.